A Hydrogel Ionic Circuit-Based Electrical Stimulation System for Restoration of Denervated Muscles After Peripheral Nerve Injuries

Project Summary: Muscle electrical stimulation (EStim) is a promising rehabilitation modality for denervated
muscles after peripheral nerve injuries. Current muscle EStim devices have limited therapeutic efficacy due to
the low EStim intensity they apply. Applying high-intensity EStim to muscles presents a significant challenge.
This is because all current devices conduct electron currents. Electrochemical reactions are required to convert
the electron currents to the ion currents at the device-tissue interface. These reactions can induce chemical
changes and temperature increase that can damage tissues when the EStim intensity is high. Thus, there is a
critical need for a new generation of muscle stimulators that can safely apply high-intensity EStim for efficacious
preservation of denervated human muscles.
The long-term goal is to develop efficacious EStim-based therapy to preserve denervated human muscles after
peripheral nerve injuries. The overall objectives of this proposal is to develop a novel EStim device that can
safely apply high-intensity EStim to improve the preservation of denervated muscles. In Specific Aim 1, we will
determine the optimal EStim device design for safe application of high-intensity EStim. Our working hypothesis
is that a wirelessly coupled, ion current-conducting hydrogel ionic circuit (HIC) device does not induce any
electrochemical reactions, so it can minimize adverse effects when applying high-intensity EStim. In Specific
Aim 2, we will determine the efficacy of high-intensity EStim applied by our device for the preservation of
denervated muscles using a pre-clinical rat peripheral nerve injury model. Our working hypothesis is that high-
intensity EStim can improve muscle preservation compared to the low-intensity EStim typically used in current
studies. The sensory recovery, motor recovery and muscle quality will be evaluated.
The rationale for this project is that the development of a wirelessly coupled, completely ion current-based
stimulator will significantly increase the EStim intensity that can be applied without causing tissue damage. This
will lead to improved muscle rehabilitation outcomes following peripheral nerve injury that is not possible with
current stimulators. Our outcome will establish an optimal device design to enable safe and efficient high-
intensity EStim application. We will also demonstrate the in vivo efficacy of high-intensity EStim protocol for
muscle preservation. Our high impact project will provide a strong justification for further development and testing
of our device for treating denervated human muscles following peripheral nerve injuries. This will ultimately lead
to better rehabilitation outcomes and improved quality of life for patients suffering from peripheral nerve injury.

Public health relevance
Project Narrative: The proposed research is relevant to public health because it will develop a novel high- intensity muscle electrical stimulation device that can effectively prevent muscle atrophy following peripheral nerve injury. This project is relevant to NIAMS’s mission by developing transformative technology with potential to maximize muscle rehabilitation outcome and to improve quality of life for patients suffering from peripheral nerve injury.